International Brotherhood of Teamsters Hazardous Materials Worker Health and Safety Training

International Brotherhood of Teamsters Consortium (IBT Consortium) developed a Biosafety Preparedness training program in response to the COVID 19 pandemic. In preparation to deliver training to front-line workers, the IBT Consortium is updating its course curricula concerning blood-borne and other infectious diseases that may affect the target populations. To ensure fiscal accountability and sound management practices, the IBT Consortium uses a comprehensive management and administrative structure that provides for multiple levels of review for program expenditures and activities.

Public health relevance
IBT Consortium Program Narrative The IBT Consortium will provide safety/health training to workers with the skills to safely transport hazardous materials/hazardous waste and work on remediation sites, thereby minimizing the risk of contamination for workers, the community and environment. The training provides workers with the ability to react to an unexpected release of hazmat/hazwaste, take appropriate actions, and limit the contamination of surrounding communities and the environment. All training will satisfy appropriate OSHA, DOT, EPA training requirements, as well as comply with the NIEHS Minimum Criteria.